Support for Vector Biology Training for Sustainable Control of Vector Borne diseases in East Africa

Vector-borne and neglected tropical diseases (VBDs and NTDs, respectively) are endemic and
emerging threats in sub-Saharan Africa (sSA). In this renewal application, scientists from Kenya Agricultural
and Livestock Research Organization, Biotechnology Research Institute (BioRI-KALRO), and Yale School of
Public Health (YSPH) will partner with Kenya Medical Research Institute (KEMRI), Gulu University (GU) and
Vector and Vector-Borne Diseases Institute (VVBDI) and their peers in Kenya, Uganda and Tanzania with
support of the East African Science and Technology Commission (EASTECO) to strengthen Vector Biology
(VB) education and research capacity in order to advance vector control applications and reduce disease
burden in East Africa. Our specific objectives are to:
Aim 1) Empower early-career researchers in East Africa.
Our training will target early-career scientists, including post-doctoral scholars and junior level faculty.
We will transfer knowledge necessary to advance the state-of-the-art laboratory and field research skills,
mathematical modeling and data management
within
broad fields of vector physiology, ecology, population
genetics/genomics and epidemiology. We will establish regional network(s) of early-career researchers in
LMIC institutions to support the next-generation of researchers and field practitioners and policy makers. Our
program will prepare trainees with necessary skills to establish independent research programs, and to advise
on sustainable and evidence-based strategies for in-country VC and disease elimination programs, and
promote public discussions and consultations to advance downstream delivery capacity of innovative and
integrated human, animal and environmental health VC technologies.
Aim 2) Develop leadership and institutional capacity to disseminate knowledge on innovative VC applications.
We will offer in-person and/or virtual training and mentorship opportunities in bioethics, proficient
clinical and laboratory practices, vector management and biosafety to early-career scientists from LMIC
institutions. We will also train faculties in manuscript preparation, grantsmanship, and editorial capabilities
and administrators in best-practices for the management of research and development (R&D) activities.
Working with our network institutions and public health agencies in the LMICs, we will identify and address
barriers to downstream application and adoption of research outputs relavant for VBZD control.
During the course of this award, we will support advanced training of 8-10 early career scientists for a
two-year period in LMIC institutions, and present up to five workshops/webinars annually to broad program
participants in different LMIC institutions. We will provide a leadership training opportunity to two advanced
researchers at YSPH for 3-months annually to advance research content and mentorship/administration skills.

Public health relevance
Research is needed to develop effective responses to vector-borne Neglected Tropical Diseases in sub-Saharan Africa. This grant will allow scientists from East Africa [Kenya Agriculture and Livestock Research Organization (BioRI-KALRO), Kenya Medical Research Institute (KEMRI) in Kenya and Gulu University in Uganda], and their Yale University collaborators, to train early career scientists in fundamental principles of vector biology and vector borne diseases and in new and emerging translational technologies for vector control. Program described in this application contains a mix of postdoctoral training for junior academicians/practitioners and thematic workshops and courses to enhance research capacity in vector biology and advance enhance vector control.